Mechanisms of CNS node of Ranvier formation

DESCRIPTION (provided by applicant): Rapid and efficient propagation of action potentials in the mammalian nervous system requires both myelination and the high-density clustering of voltage-gated ion channels at gaps in the myelin sheath called nodes of Ranvier. Although many demyelinating diseases and injuries cause disruption of nodes and nervous system dysfunction, the mechanisms that are responsible for ion channel clustering at central nervous system (CNS) nodes of Ranvier remain unknown. We propose that three distinct cellular and molecular interactions contribute to CNS node formation and maintenance: 1) interactions between axonal cell adhesion molecules and a unique CNS nodal extracellular matrix, 2) interactions between axons and myelinating glia at paranodal junctions set up a membrane protein diffusion barrier to restrict the lateral mobility of nodal proteins, and 3) interactions between nodal membrane proteins and nodal cytoskeletal scaffolds maintain high density clusters of ion channels. Thus, multiple, overlapping mechanisms may exist in the CNS to facilitate ion channel clustering at nodes of Ranvier. In this project we will undertake both cell biological and genetic methods to determine the mechanisms underlying CNS node of Ranvier formation. We will focus on the extrinsic, glial-derived interactions that are necessary for CNS node formation. In the first aim we will elucidate the molecular interactions between nodal cell adhesion molecules and CNS nodal ECM proteins. We will determine if soluble ECM proteins are sufficient to induce clustering of nodal proteins in purified neuronal cultures. In the second aim we will perform genetic analyses of single, double, and triple knockout mice lacking extracellular matrix molecules, paranodal junctions, and/or cytoskeletal interactions to uncover the existence of, and requirement for, each overlapping mechanism. PUBLIC HEALTH RELEVANCE: Disruption of nodes of Ranvier or their molecular composition is one consequence of demyelination and contributes to the pathophysiology of many diseases and injuries including multiple sclerosis and spinal cord injury. Thus, any therapeutic effort aimed at treating these diseases or reversing their devastating effects will require a detailed understanding of the mechanisms responsible for node of Ranvier formation and maintenance. Nodes have been the focus of much interest not only because of their functional importance in both health and disease, but also because their assembly represents one of the best examples of the elaborate reciprocal interactions that must occur between neurons and glial cells.

Public health relevance
RELEVANCE Disruption of nodes of Ranvier or their molecular composition is one consequence of demyelination and contributes to the pathophysiology of many diseases and injuries including multiple sclerosis and spinal cord injury. Thus, any therapeutic effort aimed at treating these diseases or reversing their devastating effects will require a detailed understanding of the mechanisms responsible for node of Ranvier formation and maintenance. Nodes have been the focus of much interest not only because of their functional importance in both health and disease, but also because their assembly represents one of the best examples of the elaborate reciprocal interactions that must occur between neurons and glial cells.